A Connectomic Analysis of a Developing Brain Undergoing Neurogenesis

PROJECT SUMMARY / ABSTRACT
Over the course of the development and into adulthood, the human brain builds neural circuits composed of
thousands of types of neurons. As new neurons are born, they are incorporated into developing and existing
circuits making connections to neurons that are nearby as well as neurons that are in distant parts of the brain.
Many neurological conditions are related to the improper growth of networks in the brain. Yet, we lack a basic
understanding of how neural circuits change as new neurons join. To address this question, this proposal uses
a novel animal model, the mollusc, Berghia stephanieae, in which it is possible to construct a cellular- and
synaptic-level wiring diagram of the entire brain at several juvenile stages as well as the adult. Using these whole
brain connectomes, the project will track the changes in specific neurons, in neural circuits, and in whole brain
networks as the number of neurons in the brain increases by over 40-fold.
Neurons will be identified by intersectional labeling of gene expression using sets of up to five in situ
hybridization chain reaction probes that label different mRNA sequences. Overlapping sets of probes will used
so that individually identifiable neurons and neuron types can be distinguished based on their patterns of gene
expression combined with their soma location and size. Additionally, in adult animals, neurons will be labeled
using fluorescent tracers applied to nerves emanating from the brain. Machine learning (ML) will be employed to
classify neuronal types based on all of these features. ML classifications of neurons across developmental
stages will be corrected by humans to enhance the predictive power of the ML.
A series of connectomes of the brains of an adult and juveniles from four stages will be constructed. The
brain will be serially sectioned. Each of the 30 nm thick sections will be imaged using a 61 beam scanning
electron microscope. The sections will be aligned and all neurons will be automatically reconstructed in 3D. The
reconstructions will include all axons, dendrites, and synapses. Again, humans will proofread the results to
correct the ML algorithm. The result will be five complete brain connectomes spanning from the early juvenile
with 500 neurons to the mature adult with over 23,000 neurons.
The developmental series will be analyzed to test hypotheses about the organization and development of
neurons, neural circuits, and entire brain networks. Changes in neural structure of identified neurons will be
tracked over development. Comparisons will be made between neural types as new neurons are added.
Complete neural circuitry for visual, olfactory, and motor systems will be determined. Finally, the project will
determine whether hubs develop around the oldest neurons or whether the network scales without concentrating
connectivity at particular hubs. The results will provide an unprecedented look at how the synaptic networks of
neurons across an entire brain change as new neurons are added.

Public health relevance
PROJECT NARRATIVE (FROM ORIGINAL GRANT) Many neurological conditions result from problems arising during development, yet a fundamental understanding of how neurogenesis adds new neurons to functioning circuits is lacking. This project creates five complete wiring diagrams of brains at different stages of development in a small tractable animal. The results will provide insights into how larger networks, including the human brain, continue to function while adding more neurons.